Structure, Orientation, and Competitive Interactions of S. Epidermidis Biofilm Proteins on Surfaces

The first step in biofilm formation is bacterial attachment to a surface. This attachment is mediated by
components on the cell surface as well as the surface itself. Understanding the chemical interactions involved
in attachment is an important part of preventing biofilm-related illness. Several proteins have been implicated in
bacterial attachment and biofilm initiation, but their behavior on surfaces is poorly understood. Moreover, few
experimental techniques exist that are able to characterize surface-bound protein behavior. This project
investigates the properties of two biofilm-related proteins in Streptococcus epidermidis, Aap and AtlE, as they
interact with surfaces. Recently developed approaches using NMR spectroscopy will be employed to study the
structure and orientation of these proteins on various nanoparticle surfaces. Nanoparticles offer a significant
increase in surface to volume ratio compared to macroscopic surfaces, and recent evidence suggests that
nanoparticle curvature does not substantially alter the nature of protein-surface interactions. This makes
nanoparticles an attractive system for studying protein-surface interactions. In this work, nanoparticles are
used to model surfaces of materials made of glass, plastic, and titanium (commonly used in medical devices),
as well as surfaces exposed to host extracellular matrix proteins. Three specific aims are proposed: (1) To
identify the structural mode of interaction between biofilm-related proteins and surfaces, NMR-based
hydrogen deuterium exchange, chemical labeling, and relaxation measurements will be used to characterize
Aap and AtlE domains bound to surfaces. (2) To understand how biofilm protein competition influences
surface binding, mixtures of Aap and AtlE domains will be studied, monitoring simultaneous surface binding
in real time. (3) To determine how biofilm proteins bind to chemically passivated surfaces, we will
explore the protein properties (e.g. charge, size) of Aap and AtlE domains that modulate binding to surfaces
coated with PEG and Tween-20. Treatment with PEG is a common strategy for reducing protein binding, but
this does not prevent binding entirely, and the reason why is not clear. Biofilms represent a major cause of
hospital-associated infection in the US, and this project will lead to a better understanding of the early stages of
bacterial attachment. This project applies novel and innovative techniques to study the chemical basis of
adsorption of Aap and AtlE, and the results will be directly relevant to other bacterial biofilms as well. The
mechanistic details revealed by this project will be useful in understanding how biofilms form, and such insights
could ultimately lead to better approaches for inhibiting the formation of biofilms on surfaces.

Public health relevance
Biofilm-related infections are a significant cause of illness in the US, and many of these infections are caused by the bacterium Staphylococcus epidermidis. One of the first steps in biofilm formation occurs when bacterial cells attach to a surface, and in this project we will characterize surface binding for two proteins implicated in staphylococcal biofilms. Examining the structure, orientation, and inhibition of protein surface binding could lead to new treatments for inhibiting the early stages of bacterial attachment.